Core Facilities for Vision Research

Project Summary/Abstract
Columbia University has a large and vibrant vision research community supported by the National Eye
Institute, with 25 qualifying R01 grants and 48 vision scientists in all. Vision research at Columbia ranges
across a gamut of topics, from genetic studies of retinal and visual brain development in Drosophila and mice
to studies of human retinal disease. Computational, neurophysiological, light microscopic, genetic,
biochemical, and clinical techniques focus on a range of problems including the development of the eye and
the visual brain, the mechanisms of ocular angiogenesis, the systems neuroscience of visual and oculomotor
behavior, and the pathophysiology, genetics, and treatment of retinal diseases such as macular degeneration,
retinitis pigmentosa, myopia, and glaucoma. To support this vision research, we are applying to renew our
National Eye Institute grant P30 EY019007, which will continue to support a set of Core Facilities for Vision
Research and enable services that could not be provided by individual research grants. The grant supports
three research cores: i) an Instrumentation Fabrication and Design Core that designs and builds custom
equipment; ii) a Computer Core that performs support and maintenance for the hundreds of computers,
including real-time laboratory computer-based interface used by the vision research community, handles
research-specific database design, integrated data storage, management and analysis with the new Genomics
Analysis Suite; and iii) an Imaging, Histology and Functional Diagnostics Core, which provides histological, in
vivo, fluorescent microscopy, OCT, and ERG services. The grant not only supports currently funded
investigators with NEI R01s, but also aids the work of vision scientists supported by other NEI funding
mechanisms, other NIH institutes, and, importantly, young investigators gathering data in order to submit their
first NEI grants. This grant facilitates collaboration among members of the Columbia vision research
community, and encourages scientists not currently engaged in vision research to use their expertise in
problems related to vision.

Public health relevance
Project Narrative Vision is a unique process, depending upon both the eye and the brain. This Core Facilities grant will support work on basic and clinical aspects of vision research, such as understanding how the eye and the visual brain develop, the brain mechanisms that underlie visual behavior, the treatment of diseases like macular degeneration, glaucoma, and myopia and the behavior of patients with ocular disease. By providing technical support, the Core modules will enable its participants to work effectively on problems related to the causes and treatment of blindness.